Antimicrobial resistance in enteric pathogens from retail meat and seafood: A NARMS Retail Food Surveillance Program in Illinois

Project Summary/Abstract
Retail raw meat and seafood pose risks of foodborne bacterial pathogen transmission to humans. Meat products
like chicken, beef, ground turkey, and pork are major sources of foodborne pathogens including Escherichia coli,
Salmonella, and Campylobacter. Seafood products at retail venues, including shrimp, tilapia, and salmon, often
carry Vibrio and Aeromonas. These foodborne pathogens from retail food products frequently show resistance
to multiple antimicrobials, posing a serious public health risk. As antimicrobial resistance (AMR) threatens food
safety and public health, monitoring AMR in these bacteria is essential to prevent the spread through the food
chain. The National Antimicrobial Resistance Monitoring System (NARMS), a U.S. public health surveillance
system, tracks AMR in humans, animals, and retail meats. Illinois—with densely populated urban centers and
agricultural regions—plays a key role in the national food supply chain. This project will enhance AMR
surveillance by supporting the FDA-NARMS program in Illinois through standardized testing of retail food
products. Fresh meat (including chicken, ground turkey, ground beef, and pork chops) will be collected twice
monthly from retail outlets randomly selected from NARMS-designated locations within Illinois, with
microbiological testing for Salmonella, Campylobacter, Escherichia coli, and Enterococcus. Seafood samples
(shrimp, tilapia, and salmon) will be tested for Enterococcus, Aeromonas, Vibrio, and other lactose fermenting
bacteria. The isolates will be serotyped and subjected to whole-genome sequencing (WGS) and molecular
testing (PCR) following NARMS protocols. All sequences will be submitted to the National Center for
Biotechnology Information (NCBI) within 2 months, and isolates will be sent to the FDA. Our work will follow
NARMS protocols and data agreements, participating in NARMS calls and working groups. This project will track
emerging AMR trends in foodborne bacterial pathogens through data derived from phenotypic and genotypic
analyses, enabling public health agencies to take appropriate measures. The specific aims are: 1) Initiate and
strengthen Illinois-wide AMR surveillance through strategic retail sampling of poultry, meat, and seafood
products; 2) Elucidate phenotypic resistance profiles and perform WGS of priority foodborne bacterial pathogen
isolates; 3) Leverage integrated genomic and metadata analyses to assess AMR trends and track dissemination
patterns across retail food sources. The long-term objective is to strengthen national AMR surveillance and
protect public health by identifying risks from resistant foodborne bacteria.

Public health relevance
Project Narrative Retail meat and seafood are significant sources of foodborne pathogens such as Salmonella, Campylobacter, E. coli, Enterococcus, Vibrio, and Aeromonas, many of which show resistance to multiple antimicrobials, posing a serious public health threat. This project will support the FDA-NARMS program in Illinois by conducting systematic sampling and testing of retail meat and seafood for antimicrobial-resistant foodborne pathogens, followed by whole-genome sequencing and molecular analysis. The goal is to enhance AMR surveillance, track emerging resistance trends, and provide data to inform public health interventions.